Improving smoking abstinence outcomes in the African American community through extended treatment

PROJECT SUMMARY / ABSTRACT
African Americans are disproportionality burdened by tobacco in the United States. African American smokers
experience the highest rates of tobacco-attributable disease, cancer incidence and mortality. Striking health
disparities exist despite the fact that African Americans have similar smoking prevalence as Whites, yet smoke
fewer cigarettes per day (cpd). To have an impact on the premature mortality of African American smokers,
effective treatment for smokers across the smoking continuum must be identified. Further, because smoking
cessation rates tend to be lower for African American smokers, it is necessary to find methods of increasing
response to pharmacotherapy to better promote abstinence in this high-risk group. Extended treatment has
been demonstrated to increase abstinence in White smokers but has never been examined in African
American smokers, who might benefit from extended medication support for quitting and for reducing relapse.
The primary objective of this study is to evaluate extended use of varenicline, the leading FDA-approved
medication for tobacco treatment, with the goal of enhancing abstinence in African American daily smokers,
including the full spectrum of light, moderate, and heavy smokers. Our specific aims are to 1) evaluate the
efficacy of extended varenicline treatment to promote smoking cessation at end of treatment (Month 6) and at
long-term follow-up (Months 9 and 12), 2) examine medication adherence over the course of treatment and its
impact on treatment outcomes, 3) evaluate change in negative affect, withdrawal, and craving across treatment
conditions and their impact on treatment outcomes, 4) identify individual factors predicting smoking abstinence,
and 5) characterize patterns of tobacco use and abstinence over the course of standard and extended
treatment. These aims will be accomplished using a two-arm, randomized design to evaluate the efficacy of
extended (6 months) varenicline treatment compared to standard (12 weeks) varenicline treatment. Baseline
randomization stratified by gender will assign participants (N=500) to receive extended treatment (EXT; 26
weeks of varenicline, n=250) or standard treatment (ST; 12 weeks of varenicline, n=250). All participants will
receive culturally-relevant, individualized smoking cessation counseling, including support for medication
adherence, and will be followed through Month 12. This study is the first to examine the efficacy of extended
varenicline treatment to increase abstinence among African American smokers, including the full spectrum of
daily smoking level. It is the first to examine extended varenicline for all smokers, not only confirmed quitters,
and among the first to examine patterns of quitting, lapse, and relapse among African American smokers.
Findings will enrich our understanding of the interrelationship of key biological factors to smoking factors and
treatment response. Success in increasing long-term abstinence rates would significantly impact clinical
practice for treatment of this high-risk group. Increased treatment efficacy will have major impact on reducing
tobacco-related disparities, morbidity, and mortality.

Public health relevance
PROJECT NARRATIVE African Americans experience the highest levels of tobacco-related disease and death, despite smoking fewer cigarettes per day than Whites, and have relatively low quit rates when stopping smoking. Finding new approaches to enhancing treatment for African American smokers is a critical public health priority, and identifying methods of improving treatment outcomes from existing pharmacotherapy is central to this goal. This study will evaluate the efficacy of extended varenicline treatment to improve quit rates in African American daily smokers of all smoking levels, with the goal of reducing tobacco-related health disparities, and thereby reducing morbidity and mortality in this high-risk group.